RENAL FUNCTION RESERVE IN CHILDREN WITH GLOMERULAR INJUURY

The response of the GRF of children with primary and secondary glomerular disease to variations in protein intake will be assessed and hyperfiltration.